The Molecular Genetics of Venous Thromboembolic Disease

Project Abstract
VTE affects 900,000 individuals in the US each year, and is highly heritable, with ~60% of lifetime risk attributable
to genetic factors. To date only 50% of the genetic factors contributing to VTE have been described. Recently,
genome-wide association studies (GWAS) of VTE have validated the contribution of common variants of
coagulation factor V (F5) and common blood group antigens (ABO) as well as smaller contributions at six other
gene loci, but have failed to identify additional variants implicated by the high heritability of VTE. Due to the lack
of a comprehensive understanding of the genetic risk factors for VTE, current genetic testing cannot accurately
predict an individual’s susceptibility for VTE and does not adequately inform clinical decision making for VTE
prevention and treatment. Therefore, there is a critical need for more complete genetic risk data to help clinicians
predict which individuals need treatment to prevent incident or recurrent VTE. The objective of this proposal is
to identify new, high impact genetic risk factors for VTE and to begin to uncover the molecular mechanisms
affected by newly identified risk variants. The central hypothesis of this proposal is that a large proportion of the
unknown genetic risk factors for VTE are rare variants that cluster in a limited number of genes driving risk
primarily through loss of function. These yet to be described variants contribute to the heritability of VTE but are
undetectable by GWAS because they are individually too rare. To identify mutations that alter VTE risk,
collapsing rare variant analyses will be performed with whole-exome sequencing data from a previously collected
VTE case/control study. Subsequent targeted DNA sequencing in an extensively characterized young healthy
cohort combined with plasma antigen assays will inform the molecular mechanisms leading to a prothrombotic
state in individuals harboring VTE risk mutations. Functional studies of the newly identified VTE risk gene STAB2
to identify quantitative or qualitative deficiencies in the VTE case variants will be performed. Additional functional
assays will be developed after identification of physiologic stabilin-2 ligands through proximity dependent
biotinylation and proteomics. Furthermore, to comprehensively characterize the effect of missense mutations on
stabilin-2 function, focused mutagenesis studies of stabillin-2 domains will be performed. Upon successful
completion of the proposed research, we expect to have identified previously undescribed gene deficiencies that
explain a substantial proportion of the inherited risk for VTE. We also expect to define the basic mechanisms
underlying genetic associations in STAB2 and other novel genetic associations. The ability to execute both
genome-wide screens and “wet lab” experimentation is facilitated by the applicant’s established cross-
disciplinary collaborations. The innovative use of DNA sequencing and rare variant analyses in well
characterized human cohorts, combined with in vitro mutagenesis and proteomic studies will lead to new
knowledge that provides reproducible, clinically useful and personalized information for prognosis, prevention,
and treatment of VTE.

Public health relevance
Project Narrative The proposed research is relevant to public health and the mission of the NHLBI because it addresses a need to understand the genetic determinants of venous thromboembolic disease (VTE), a severe disease that affects ~900,000 individuals a year in the United States. This project takes advantage of previously well characterized human cohorts through next generation sequencing studies and subsequent in vitro experiments to improve the chance of uncovering functional genetic variants altering the risk for venous thromboembolism. These findings should provide new tools for the prediction of VTE risk, potentially leading to major advances in the diagnosis and individualized treatment of patients with thrombophilia.